Epitranscriptomic regulation in the mammalian nervous system

PROJECT SUMMARY
Epitranscriptomics, analogous to the epigenetic code formed by DNA and histone modifications, is the study of
more than 170 chemically distinct types of RNA modifications, which modulate nearly all aspects of RNA
metabolism, such as splicing, translocation, decay, stability, and translation. The recent profound success of
COVID19 mRNA vaccines utilizing the pseudo-uridine modification highlights the translational potential of
epitranscriptomics. Emerging evidence suggests diverse roles and mechanisms of dynamic RNA modifications
in the mammalian nervous system and the association of epitranscriptomic dysregulations with developmental,
neurological, psychiatric, and degenerative brain disorders. The majority of recent epitranscriptomic studies
used cultured immortalized cell lines and the physiological functions of various RNA modifications remain
largely unexplored. Recent technical advances in human induced pluripotent stem cell (iPSC)-derived brain
organoids and genome editing open doors to investigate epitranscriptomic regulation in human brain
development processes and associated brain disorders. The overarching goal of this research program is to
investigate roles and mechanisms of epitranscriptomic regulation in the development and function of the
mammalian nervous system, and pathological consequences of disrupting these processes, using both mouse
and human iPSC-derived 2D and 3D brain organoid models. There are three interrelated projects designed to
test innovative hypotheses and generate foundational data for the field. In Project 1, we will focus on the
development of the hypothalamus, an understudied brain region that regulates many key physiological
functions, such as sleep, reproduction, and feeding, through its distinct nuclei. Based on our preliminary finding
of adult-onset obesity of mice with defective m6A signaling, we will test the hypothesis that m6A signaling
regulates the fate specification of neural stem cells in the arcuate nucleus for generating feeding-related
neurons both in mice and human arcuate organoids. In Project 2, we will use novel sequencing technology to
reveal the landscape of locally translated transcripts at synapses and investigate the role of m6A signaling in
regulating activity-dependent local translation of these transcripts at synapses in the mouse hippocampus and
human hippocampal organoids. In Project 3, we will focus on several risk genes associated with microcephaly
that encode writer proteins for diverse epitranscriptomic modifications beyond m6A. We will generate isogenic
iPSC lines and genetically modified animal models to test the functional roles and mechanisms of these RNA
modifications in cortical neurogenesis. Together, we will use several orthogonal approaches to investigate
functional roles and mechanisms of neuroepitranscriptomics in regulating the mammalian nervous system and
its causal roles in mediating some forms of developmental pathology. The research program will also provide a
platform to train the next generation of scientists from diverse backgrounds at different career stages.

Public health relevance
NARRATIVE The overarching goal of this research program is to investigate the roles and mechanisms of RNA modification in the development and function of the mammalian nervous system, and pathological consequences of disrupting these processes, using both mouse and human iPSC-derived 2D and 3D brain organoid models.